Administrative Core

The goal of the Administrative Core for the PSM/MCC Partnership is to provide the necessary oversight and organization for the scientific and administrative aspects of the Partnership. Administrative and coordinating activities will take place at both institutions, with continuous communications being one of the principal responsibilities of both Administrative Cores. Each Administrative Core will have two Program Managers that will report directly the Principal Investigators at each institution: The Program Managers will be responsible for scheduling and planning the internal meetings of investigators, internal advisors and key project and core personnel. Moreover, they will coordinate all aspects of visits by the members of the Steering Committee to the annual meeting. The Administrative Core will also be responsible for documenting all of the activities of the Planning and Evaluation Core. The Administrative Core will support all projects, programs and cores in the Development Core.